Surveillance Monitoring for ART Toxicities (SMARTT) Study

Project Summary/Abstract
The Surveillance Monitoring for ART Toxicities (SMARTT) study was developed by the Pediatric
HIV/AIDS Cohort Study (PHACS) network to evaluate the safety of in utero antiretroviral (ARV) exposures on
children born to mothers with HIV. The study has been highly productive, informing national and international
guidelines for safe and effective ARV regimens during pregnancy. The SMARTT study uses an innovative
trigger-based surveillance approach for identifying adverse events (AEs) that may be attributed to prenatal and
perinatal ARV therapy exposure. All children receive periodic clinical and laboratory evaluations and only those
meeting certain thresholds or “triggers” receive additional assessments to evaluate specific AE criteria
designated as “cases”. The study opened to enrollment in 2007, and as of October 2019 has enrolled over
4000 infants and children who are HIV-exposed but uninfected (CHEU) born to mothers with HIV. By 2019,
33% of children had met case status in at least one domain. Pregnant women living with HIV are increasingly
receiving combination antiretroviral treatment at the time of conception, and newer ARV medications approved
over the last decade have raised concerns regarding possible increased risk of congenital anomalies, preterm
birth, and other adverse birth outcomes. As the landscape of treating HIV in pregnancy evolves, there is a
need to develop the most cost-effective and informative study designs for future monitoring of ARV safety
among CHEU.
Building on the established experience of the PHACS network, we will enroll 200 mother-infant pairs
over 5 years from 21 clinical sites to evaluate potential adverse birth outcomes and alterations in growth and
neurodevelopment, and cardiometabolic, maternal, and oral health based on follow-up from birth through age 5
(intensive follow-up cohort). We will also conduct targeted long-term follow-up through age 17 years
among CHEU identified as AE cases based on the SMARTT trigger design, along with a comparison cohort
of 800 randomly-selected CHEU (stratified by clinical research site), to evaluate persistence, resolution, and
longitudinal profiles of health functioning across multiples domains of interest (extended follow-up cohort). This
large cohort will serve as a platform for multiple separately funded emerging research pilots, and allow synergy
with other PHACS projects. Innovative epidemiologic and statistical methods will be used to analyze this large
dataset to promote improved understanding of both child and maternal health in relation to HIV.

Public health relevance
Project Narrative The Surveillance Monitoring for ART Toxicities (SMARTT) Study of the Pediatric HIV/AIDS Cohort Study (PHACS) network has been enrolling and following infants and children who are HIV-exposed but uninfected (CHEU) born to women with HIV, with over 4000 CHEU enrolled over the past 14 years. The primary goal of the PHACS SMARTT study is to evaluate the short-term and long-term safety of maternal antiretroviral treatment (ART) during pregnancy on health outcomes in CHEU across a wide range of domains, including growth, neurodevelopment, cardiometabolic, hearing, language, oral, and maternal health. This proposal describes our strategy for continued enrollment and follow-up of CHEU to inform ART guidelines and optimize the efficacy and safety of ART use in pregnancy.